Characterization of the lupus nephritis microRNAome

ABSTRACT
The goal of this investigation is to identify and characterize the role of microRNAs (miRNA) in serum exosomes on
the risk of Systemic Lupus Erythematosus (SLE), and among patients with SLE, the risk of, and rate of progression
to, lupus nephritis (LN). SLE is a prototypic autoimmune disease that is characterized by the presence of antinuclear
autoantibodies, complement activation and multisystem organ damage, including LN, which accounts for
significant morbidity and mortality particularly among persons of African American and Amerindian ancestry. The
basis for this disparity remains poorly understood. Although the etiology of SLE is unclear, combinations of genetic
and environmental factors play a causal role. Despite the discovery of several SLE susceptibility loci, variation in
DNA sequence alone accounts for only a small fraction of common complex disease and efforts to utilize these
markers to classify or monitor SLE clinical course, and the development of LN, have not yet been successful. Recent
advances in transcriptome sequencing offer new opportunities to characterize miRNAs as novel biomarkers, which
could significantly change the paradigm of SLE clinical monitoring. We will test the overarching hypothesis that
distinct serum exosome miRNAs will correlate with the presence of SLE and among patients with SLE, the presence
of and time to, LN, and that miRNAs influence the severity and rate of progression of LN by altering target gene
expression. We intend to capitalize on a unique opportunity to explore these relationships in a large, ancestry
diverse, well-characterized population of established SLE while taking advantage of recent advances in
bioinformatics and whole transcriptome sequencing. Our objective to characterize the influence of exosome
miRNAs relative to the risk of SLE and among these patients, the risk and tempo of LN in paired blood and target
tissue fills a critical gap in knowledge required to advance efforts to detect, prevent and manage LN among SLE
patients, as well as to identify new therapeutic targets. Findings forthcoming from this investigation will fill a
critical gap elated to the disparate trends of SLE etiology and progression, which differ by ancestry, and may
translate to other kidney phenotypes including those observed in immune-mediated cancers.

Public health relevance
PROJECT NARRATIVE The purpose of this study is to identify serum exosome microRNAs associated with the risk of lupus and among these patients, the risk and rate of progression of lupus-associated nephritis, and to characterize the role of miRNAs in regulating gene transcription (mRNA). These relationships are important to provide insight into novel biomarkers, which can be used to predict, classify and ultimately treat lupus and lupus-associated nephritis, which disproportionately affects women and ethnic minority patients. The knowledge gained from this study may help us to lower the risk of lupus and lupus-related clinical manifestations and to manage and treat it more effectively.